Novel Therapeutics for Acquired Thrombotic Thrombocytopenic Purpura

Project summary
The overall goal of the proposed study is to understand the mechanism underlying allosteric regulation of
ADAMTS13 function, to determine the therapeutic efficacy of rADAMTS13-loaded platelets in acquired
thrombotic thrombocytopenic purpura (TTP), and to elucidate the mechanism underlying platelet uptake of
rADAMTS13. In Aim 1, we will use the novel deuterium-hydrogen (HX) and mass spectrometry (MS) and other
biophysical tools to determine the role of distal C-terminal domains in allosteric and pH-dependent regulation of
ADAMTS13 function; In Aim 2, we will determine therapeutic efficacy of ADAMTS13-loaded platelets in murine
and human models of acquired TTP; and In Aim 3, we will determine the mechanism underlying platelet
endocytosis of ADAMTS13 by using β3-/-, arf6-/-, and VAMP3-/- mice. We believe that the results of the
proposed study will shed new light on the fundamental biology of ADAMTS13, help to understand the
pathogenesis of acquired TTP, and to develop a novel therapeutic strategy for this fatal syndrome and perhaps
other arterial thrombotic disorders.

Public health relevance
Project Narrative The proposed study focuses on understanding the molecular mechanism underlying allosteric regulation of ADAMTS13 function and substrate specificity, determining the therapeutic efficacy of rADAMTS13-loaded platelets in murine models of acquired TTP, and elucidating the mechanism of receptor-mediated endocytosis of rADAMTS13.